A biochemical approach towards subcellular, label-free molecular imaging

ABSTRACT
Mass spectrometry-based spatial analysis has enabled label-free investigation of a broad range of endogenous
biomolecules—lipids, peptides/proteins, metabolites, and glycans—in intact biological and clinical specimens.
Rapid development in this area has contributed enormously to the current spatial omics research. However,
the routine spatial resolution of MALDI-based mass spectrometry imaging, arguably one of the most widely
used mass spectrometry imaging techniques today, is about tens of micrometers on a conventional mass
spectrometer. This resolution limit imposes a roadblock towards label-free analyses of specimens at single-cell
or subcellular level in existing mass spectrometry laboratories.
Recent development of expansion microscopy has seen considerable success in generating fluorescence
images of biological structures beyond the intrinsic spatial resolution of an optical system. Such capability has
led to democratization of super-resolution fluorescence microscopy in biological and clinical laboratories.
However, current expansion microscopy protocols and chemistries are not compatible with mass spectrometry
imaging or analyses.
The main objective of this proposal is to establish a biochemical process of sample expansion to push the
spatial resolution of existing mass spectrometry imaging pipelines to the subcellular regime, namely, to a few
micrometers and beyond. Towards this goal, we will develop a sample polymerization and digestion protocol
optimized for mass spectrometry imaging, in which the endogenous lipids and proteins are tethered to a
swelling polymer network and can be subsequently analyzed on a MALDI mass spectrometer. Our
experimental approaches include (1) development of a biochemical pipeline of tissue polymerization and
expansion for lipid mass spectrometry imaging; (2) extension of the pipeline to multiplexed lipid and protein
detection and imaging. Successful completion of this proposal will provide the community with a label-free,
subcellular-resolution molecular imaging modality without modifying the existing instrumentation.

Public health relevance
PROJECT NARRATIVE The proposed study is highly relevant to public health as it introduces a new label-free molecular imaging modality capable of spatially mapping intact biological and clinical samples at subcellular resolution. This new approach will allow for investigation of subcellular anatomy and pathology with conventional mass spectrometry instrumentation. Furthermore, it will enable multiplexed analysis of biomarkers as well as high- precision diagnosis of diseases in existing laboratories.